SAFETY, TOLERANCE, &PHARMACOKINETICS OF PMEA IN HIV INFECTED PATIENTS

This protocol was to study the safety, tolerance, pharmacokinetics and anti-HIV activity of multiple oral doses of Bis-POM PMEA in HIV-infected individuals. The study is complete.